Xenopus as a Model System for Hydrocephaly and Ependymal Ciliogenesis

Project Summary Congenital Hydrocephalus (CH), the pathological expansion of the cerebral ventricles due to cerebrospinal fluid (CSF) accumulation, is a common birth defect (1 in every 1000 births) with high mortality and morbidity. In fact, CH is the most common disease treated by pediatric neurosurgeons and despite advances in surgical technique, palliation in many patients remains inadequate. In part, these challenging cases may be due to our incomplete understanding of hydrocephalus pathogenesis. While advances in genomics are beginning to identify candidate genes that may cause CH, we lack genetically tractable animal models where pathogenesis can be analyzed. In our recent work, we paired optical coherence tomography imaging (OCT) with the frog Xenopus tropicalis to model human congenital hydrocephalus. We demonstrated that OCT imaging of mutant tadpoles can readily detect hallmarks of human hydrocephalus including aquaductal stenosis and/or ventriculomegaly. In this proposal, we seek to further advance this model and develop Xenopus as a model system that can evaluate CH candidate genes and distinguish ciliary vs. non-ciliary pathogenesis mechanisms. Our central hypothesis is that the pathogenesis of CH due to ciliary vs. non-ciliary mechanisms will be discretely different with respect to ventricular morphology, CSF flow network, and neural progenitor cell fate, which can have important implications for treatment.

Public health relevance
Project Narrative Many infants are born with excessive fluid in their brain, which is known as hydrocephalus, affecting 1/1000 live births. Our understanding of hydrocephalus is incomplete, which makes designing effective treatments much more difficult. We propose to develop frogs as a rapid and effective model for human hydrocephalus and this model can lead to new insights into how hydrocephalus forms, providing an exciting avenue for us to understand the disease process and design new treatment options.